FLUOROUS REAGENTS IN TRADITIONAL/COMBINATORIAL SYNTHESIS

DESCRIPTION: The goal of this grant is to develop general new methods for both traditional and combinatorial synthesis that use phase separation techniques for purification. The principal investigator notes that the fluorocarbon fluid (or fluorous) phase is introduced as a neglected phase that can be combined with the traditional phases - solid, gas, organic, and water - to provide simple new options to synthesize organic molecules. It is stated that the synthesis of a new class of fluorous tin reagents is proposed, and the uses of the reagents in both traditional and combinatorial synthesis are developed. The reagents include tin hydrides, aryl and allyltins, and ditins. All bear long perfluorocarbon tails (to confer fluorous solubility) and hydrocarbon spacers between the tin and the tails (to maintain normal reactivity). It is noted that in appropriate solvents like benzotrifluoride, the reagents behave like normal organic compounds, yet they can still be separated from other classes of organic compounds by liquid-liquid extraction. The principal investigator indicates that the chemistry is presented as a prototype for development of reagents of a new type of combinatorial synthesis. He goes on to say that in this new combinatorial method, the substrate is in the organic liquid phase (not the solid phase) and it is separated from other reaction components which are all gases, solids (polymer bound reagents), or are soluble in water or fluorous phases and that in the long term, simultaneous, parallel, multistep synthesis should be possible without chromatography. It is also noted that the fluorous concept is also extended to fluorous substrates, and this provides new options for combinatorial chemistry. The principal investigator indicates that work in this area is designed to provide "demonstration" experiments (proofs of principle) of both new liquid-liquid phase separation techniques, and new fluorous chromatographic techniques. It is noted that experiments use new fluorous silyl groups and are fashioned after important traditional and combinatorial reactions (like the Ugi and Biginelli reactions) to provide a basis for comparing the new methods with existing ones.